Addressing parental tobacco use in Somali immigrant families: Adapting an evidence-based intervention in pediatric primary care

PROJECT SUMMARY/ABSTRACT
The overall long-term goal of this proposal is to provide the training, career development, and mentorship that
will result in Dr. Wilhelm’s ability to develop an independent program of research that reduces tobacco-related
health inequities among U.S. immigrants. The proposed study will modify an existing evidence-based parental
tobacco cessation intervention (the Clinical Effort Against Secondhand Smoke Exposure, or CEASE) delivered
in pediatric primary care clinics to address shared tobacco use determinants and barriers to smoking cessation
treatment among Somali Americans, an immigrant population facing significant combustible tobacco use
disparities. This new intervention, CEASE+, will increase access to and utilization of tobacco cessation
resources for Somali parents. The goal of Aim 1 is 1a) to conduct focus groups with Somali parents who
smoke and non-smokers who live with adults who smoke to identify how to modify clinic-based parental
tobacco cessation treatment within pediatric primary care and 1b) to use these results to modify CEASE
components and delivery to develop the new intervention, CEASE+. In Aim 2, we will conduct a pilot study of
the new intervention, CEASE+, to evaluate its feasibility and acceptability for Somali parents. The goal of Aim
3 is to assess parent, clinician, and staff experiences with CEASE+ components and delivery strategies within
pediatric primary care clinics to inform future modifications. Ultimately, the completion of this study will provide
foundational data that will guide CEASE+ modifications for a future definitive test via a fully powered clinical
trial in Somali immigrant populations. During the five years of this career development award, Dr. Wilhelm
plans to develop expertise in 1) developing and refining tobacco prevention and control behavioral
interventions using community-engaged research approaches, 2) using mixed methodologies within
intervention development and testing, and 3) designing and conducting clinical trials. These areas of new
training are essential for Dr. Wilhelm to be able to achieve her long-term career goal of becoming an
independent investigator who develops and tests interventions aimed at reducing tobacco use within U.S.
immigrant and refugee communities. The proposed research will be conducted within the M Health Fairview
Health System, a large healthcare system affiliated with the University of Minnesota that serves a diverse
population of immigrants and includes the site for Dr. Wilhelm’s clinical practice. Dr. Wilhelm has a strong
mentorship team that includes world-renowned academic scientists in the fields of tobacco prevention and
control and she has a rigorous career development plan that will support her continued development into a
successful independent investigator. The result of this proposal and investment in Dr. Wilhelm’s continued
training have the potential to dramatically reduce tobacco use disparities within U.S. immigrant populations and
their downstream effects on immigrant families.

Public health relevance
PROJECT NARRATIVE Smoking is a significant and growing concern within U.S. Somali immigrant populations, who experience unique barriers to accessing and using tobacco treatments developed for the general population. Household smoking exposes Somali families to second- and thirdhand smoke with related negative health consequences and influences children’s tobacco use beliefs and future behaviors. This project will modify an evidence-based intervention to develop and pilot test a new parental cessation intervention delivered in pediatric primary care clinics to increase the delivery and use of tobacco treatment among parents within Somali immigrant populations.